Southeast Collaborative Alliance for Stroke Trials (SE-CoAST)

The burden of stroke continues to disproportionately impact the Southeast United States – the so-called
Stroke Belt. Reaching these populations for stroke education, prevention, acute treatment, rehabilitation, and in
particular participation in clinical research, remains a challenge. Developing a highly functional clinical and
research multicenter infrastructure to engage these populations at high risk for stroke is critical to change the
disproportionate stroke burden.
Stroke care and research, from prevention, through acute treatment, and finally through recovery /
rehabilitation, are best provided and performed in the context of multidisciplinary healthcare teams. Stroke
Systems of Care, integrating healthcare resources across a geographic region, are recognized as best
practice, ensuring optimal care within the region. Research is also best performed working within the existing
clinical stroke systems of care, capitalizing on areas of alignment – patient education, engagement, stroke
awareness in the healthcare community, and awareness of research participation opportunities in all
healthcare settings.
In this application, the expanded Southeast Collaborative Alliance for Stroke Trials (SE-CoAST) and its
investigators remain committed to serving as a Regional Coordinating Center in StrokeNet. SE-CoAST is now
an expanded, robust collaboration between 4 tertiary care academic medical centers situated in the heart of
the Stroke Belt: the Medical University of South Carolina along the SC coast, the Augusta University in eastern
GA, the Greenville Heath System in the upstate of SC, and the Palmetto Health / University of South Carolina
Health System in the midlands of SC. The greatest strength of this expanded network is our existing
partnerships in research and stroke care delivery. SE-CoAST now serves nearly the entire state of SC and a
large proportion of GA, given the breadth of our catchment areas as well as our significant telestroke presence
across the Southeast. The overall goals of SE-CoAST remain: 1) to leverage the SE-CoAST organization to
increase the number of residents of our states participating in acute, prevention and recovery StrokeNet trials;
2) to continue our leadership roles in StrokeNet activities nationally; 3) to utilize SE-CoAST preclinical
researchers in developing promising therapeutic interventions for study within StrokeNet; 4) to continue to
support and enhance the career development of our StrokeNet scholars.

Public health relevance
SE-CoAST provides a large, capable, integrated clinical trials network throughout South Carolina and eastern Georgia, encompassing the “buckle” of the StrokeBelt. The SE-CoAST network brings research opportunities to communities at highest risk yet often underrepresented in stroke clinical trials. Successful StrokeNet clinical trials conducted in SE-CoAST will provide insights into the generalizability of successful therapies.